Leadership, Planning & Evaluation

LEADERSHIP, PLANNING AND EVALUATION: ABSTRACT
Roy A. Jensen, MD, serves as the Vice Chancellor and Director of The University of Kansas Cancer Center
(KUCC). Jensen has assembled an experienced and nationally recognized team of leaders in basic science,
cancer prevention and control, translation science, health equity, clinical care, and education to help him
actuate the vision to establish KUCC as a world-class cancer center that is at the forefront of discovery,
development and implementation of knowledge, technology and novel therapeutic agents for the treatment and
prevention of cancer. Jensen’s Senior Leadership team includes Andrew K. Godwin, PhD (Deputy Director),
Shrikant Anant, PhD (Associate Director for Basic Science), Christie Befort, PhD (Associate Director for
Cancer Prevention and Control), Ronald Chen, MD, MPH (Associate Director for Health Equity), Teresa
Christenson, ASA (Assistant Vice Chancellor and Associate Director for Administration), Matthew Mayo, PhD,
MBA, FASA (Associate Director for Shared Resources), Weijing Sun, MD, FACP (Associate Director for
Clinical Research), Scott Weir, PharmD, PhD (Associate Director for Translational Research), and Danny
Welch, PhD (Associate Director for Education). This Senior Leadership team constitutes the Associate
Director’s Council and works together to foster collaborative initiatives across disciplines and campuses, define
areas of strength, address areas of weakness, and integrate basic scientists and clinicians for both the
advancement of basic discoveries and training and education efforts. Jensen and his Senior Leadership team
join research program leaders, communication leaders and health system leadership to form the Leadership
Council. The Leadership Council ensures all parties are aware of and integrated into KUCC strategic initiatives
that will help KUCC achieve its goals and aims. The KUCC External Advisory Board (EAB) provides objective
review and critical guidance for the research programs, administration, shared resources, and clinical research
infrastructure. Both internal and external planning and evaluation activities are an essential component of
KUCC’s continued and steady improvement over the past grant period (2016-2020) and will continue to play an
essential role in the future. Overall, Jensen and the KUCC Senior Leadership team have effectively utilized the
Cancer Center Support Grant to put in place a vigorous and robust process of vision setting, evaluation of
progress, implementation of improvements, and planning for the future.